Developmental Research Program

PROJECT SUMMARY

The objective of the SPORE Developmental Research Program (DRP) is to identify and support exciting prostate cancer research and ensure a continuous renewal of high-quality scientific endeavors within the SPORE. The program will recruit across multiple disciplines and backgrounds to bring fresh ideas and new approaches to prostate cancer. Applications will be solicited broadly and reviewed fairly by a highly qualified and engaged committee. DRP recipients will become part of the SPORE community with exposure, feedback, and access to core resources. Progress will be monitored, and recipients will be helped and encouraged to apply for other funding opportunities. Overall, the DRP will maximize the chance that new and cutting-edge concepts supported by promising pilot data have the capability to receive larger grant funding and ultimately impact the field. This will be achieved through the following specific aims: 1) Foster the development of innovative and promising prostate cancer research by providing seed funding to the highest rated projects solicited from RFAs; 2) Identify and prioritize solicitations focused on areas of with the potential to have the highest impact of improving the outcome of patients with prostate cancer; 3) Monitor the progress of developmental projects, provide critical and timely feedback, and encourage and enable promising DRP projects to compete for extramural peer-reviewed funding. When necessary and promising, promote the most meritorious DRP projects to full SPORE research projects; 4) Bring new investigators into prostate cancer translational research.

Public health relevance
DRP NARRATIVE The Developmental Research Program (DRP) of the DF/HCC Prostate Cancer SPORE is intended to identify and support innovative prostate cancer research projects that will maximize the chance that new and cutting-edge concepts have the capability to ultimately impact the field. By achieving this, the SPORE DRP will facilitate the advancement of research projects from pilot to sustainable status and achieve competitive extramural funding.